Evaluation of siRNA based drugs as pro-regenerative disease-modifying therapeutics for age-related olfactory loss

PROJECT SUMMARY
Age-related smell dysfunction – reduction, absence, and/or distortion – termed presbyosmia, is a major and
completely unmet health care need with a prevalence in people over 80 years old of 50%. Presbyosmia is
associated with serious consequences including nutritional compromise, increased risks of toxic exposure,
diminished quality of life and heightened 5- and 10-year mortality rates. The capacity of the adult olfactory
epithelium (OE) to renew and regenerate the population of olfactory sensory neurons (OSNs) depends on the
life-long persistence and proper function of stem cells. The pathological changes underlying presbyosmia are
due to the disordering and eventual depletion of the normally active olfactory stem and progenitor cells, namely
globose basal cells (GBCs), and the disappearance of the OSNs. In this setting of neurogenic exhaustion, the
reserve stem cells, namely the horizontal basal cells (HBCs), remain dormant despite the neurogenic
exhaustion and disappearance of GBCs. In contrast, if the OE is damaged by an olfactotoxin, the HBCs
activate and contribute to the repair of the epithelium. The key to the activation of HBCs and their rejuvenation
of the olfactory epithelium is the transcription factor Np63, which is the master switch that controls the cycle
of dormancy-activation, such that it is necessary and sufficient to suppress levels of p63 to shift the HBCs out
of dormancy and into active mode. This STTR application from Rhino Therapeutics, Inc. and Tufts University
School of Medicine seeks to advance the therapeutic strategy of using a p63-targeting siRNA drug to
synthetically activate the HBCs and drive their participation in OE repair. Substantial preliminary data suggest
this is a viable approach. The three Specific Aims of the project will 1) establish the sequence, dose, and
duration of exposure for the optimal siRNA on cultured human and mouse HBCs, and rule out off-target
effects; 2) demonstrate the efficacy of the preferred siRNA agent and regimen for activation of the HBCs in
vivo in a mouse model of neurogenic exhaustion; 3) engender a preclinical demonstration of compound
efficacy by xenotransplanting in vitro siRNA-activated human HBCs into the OE of immunocompromised rats,
demomstrating engraftment of the HBCs, and monitoring their differentiation into the constituent cells of the
host OE. Completion of the Aims will constitute an important and substantive step towards assembly of a
compelling data package on the way to IND-designation and phased clinical trials of a first-in-field drug for
treating presbyosmia and potentially other forms of smell dysfunction.

Public health relevance
PROJECT NARRATIVE Diminishment or distortion in the sense of smell (olfaction) with age is common, an unmet health care need, and compromises quality of life, nutritional status, and personal safety. The olfactory stem cells and the sensory neurons in the nose disappear, and the population of dormant stem cells, called horizontal basal cells (HBCs), that are held in reserve fail to activate, despite the pathological changes in the tissue. Ultimately, we seek to synthetically activate the HBCs by developing and treating with an siRNA drug as the first approved therapy for treating age-related smell loss; our goal is closely aligned with one of the mission areas of the National Institute on Deafness and Other Communication Disorders.